Rheb 1 and mTORC1 Signaling

Project Summary
mTORC1 as an essential signaling pathway for drug addiction. In its canonical role, mTORC1 responds to the
energy and nutrient status of cells to control fundamental processes that control cell growth and reestablish
homeostasis. mTORC1 is also dynamically activated by cocaine in neurons that express D1 dopamine
receptors (D1R) and inhibition of mTORC1 prevents behavioral effects of cocaine including cocaine self-
administration. Accordingly, it is important to understand how mTORC1 is activated in neurons and how
mTORC1 signaling contributes to effects of cocaine. Aim 1 tests the hypothesis that mTORC1 signaling is
induced as part of the homeostatic scaling process that controls the strength of excitatory synapses.
Preliminary studies indicate that Rheb1, which is essential for mTORC1 activation, associates with group 1
metabotropic glutamate receptors and endosomes that move synaptic proteins from the postsynaptic spine to
sites of protein degradation in the dendrite. Studies will examine trafficking of Rheb1 and test the role of
adaptor proteins that may couple Rheb1 to glutamate receptors and play a role in mTORC1 activation. The
role of the amino acid sensor GATOR2 will also be examined in mTORC1 activation in neurons. Aim 2
examines the hypothesis that mTORC1 functions as a co-stimulatory pathway for D1R signaling. This
hypothesis builds upon use state of the art mass spectroscopic analysis of phosphoproteins to identify
signaling crosstalk between mTORC1 and D1R. Studies will also test the hypothesis that persistent activation
of mTORC1 can block D1R behaviors by “occluding” D1R signaling. Aim 3 tests the relevance of biochemical
signaling pathways in behaviors relevant to cocaine addiction including self-administration and reinstatement
after extinction. These studies will define essential mechanisms of mTORC1-D1R signaling important for drug
addiction.